Population Data Use and Management Core

Project Summary/Abstract: POPULATION DATA USE AND MANAGEMENT RESOURCE CORE
The Mount Sinai Older American Independence Center (MS-OAIC) aims to improve the independence and
quality of life for older adults with serious illness, with a focus on dementia, implementation science, and health
disparities. The Population Data Use and Management Core (RC-PDM), one of three resource cores, provides
the technical and analytic support for MS-OAIC investigators using a growing range of existing populationbased
data sources, including the National Health and Aging Trends Study (NHATS), Health and Retirement
Study (HRS), Medicare Current Beneficiary Study (MCBS), and Medicare claims. These data provide highquality
information capturing the demographic, socioeconomic, health, function, household, and regional
context of older adults along the life course. This has allowed us to support novel and timely research on the
drivers and outcomes of serious illness for older adults and their families. RC-PDM coordinates a consulting
program that supports investigators in the technical aspects of accessing data and navigating regulatory
processes, dataset-specific analytic approaches (e.g. data structures, sampling, and design), and direct
analytic support for OAIC investigators (e.g. estimating cohort sizes and selecting outcome measures) as well
as Developmental and External projects (DPs/EPs). RC-PDM has developed a library of technical resources to
assist investigators with data requests, institutional review board applications, and data management. For this
renewal of the MS-OAIC, RC-PDM aims to continue to build its population data resources through the addition
of a robust data set of all New York State health care encounters (the Statewide Planning and Research
Cooperative System, SPARCS), a growing clinical database capturing geriatric and palliative care at Mount
Sinai, an industry dataset of healthcare organizations mergers and acquisitions, and data from older adults
with dementia from clinics across the country (the National Alzheimer’s Coordinating Center UniForm Data
Set). RC-PDM will support a DP to create a compendium of regional measures that will be linked to the MCBS
and will be an asset for research conducted in the new geospatial hub of the MS-OAIC research methods core
and for investigators interested in using any of our datasets with consideration of regional context. We will
continue to conduct research to harmonize variables across datasets, focusing on markers of frailty and
comorbidity, and will support an EP to develop new data resources better specifying the insurance benefits and
costs for those enrolled in Medicare Advantage that can be linked to claims data, the HRS, NHATS, MCBS,
and SPARCS. Finally, in our close collaboration with the REC, we remain focused on supporting early career
scientists, who can substantially benefit from efficient access to secondary data that does not require timeintensive
primary data collection and yet captures the experience of a representative heterogenous population
of older adults using high-quality assessments. In summary, we will continue to expand our population data
resources to support impactful and timely research to improve the lives of older adults with serious illness.